Internal Monitoring of Eye Movement in Schizophrenia

Both normal and schizophrenic subjects are asked to follow jumping target lights as their eye movements are monitored. The target lights are shown for brief periods and then extinguished before any eye movements are made, i.e. remembered targets. In one task a sequence of lights are shown and subjects are asked to move their eyes to the locations of the remembered sequence in the dark. In this way we are able to look for evidence of a defect in spatial location updating in subjects with schizophrenia. This study was approved by the IRB in September 2010. No subjects have been recruited to date because of laboratory software and equipment problems with a video eye tracker. These problems have been addressed and we hope to soon start recruiting subjects. No results have been obtained to date.